MULTIDISCIPLINARY ONCOLOGY RESEARCH CENTER

This application seeks continued support for our Oncology Research Center for the period of July 1, 1980 through June 30, 1985. In this request, we are seeking support for senior leadership, Center administration, Office of the Associate Director for Cancer Control, Center development, ORC Internal and External Scientific Review, Membrane Biology Core Laboratory, Tissue Culture Core Laboratory, Pharmacology and Experimental Therapeutics core laboratory, Nude Mouse Facility, Tissue and Serum Bank, Statistical Center, and the Clinical Operations Office. These components represent the critical cohesive mass necessary to maintain a stable environment in which to continue to develop our research, education and control programs.